Immune receptor degradation for immune evasion of head and neck cancer

PROJECT SUMMARY
Human papillomaviruses (HPVs) cause 5% of all human cancers, including most cervical cancers and
approximately 25% of head and neck squamous cell carcinomas (HNSCCs). The alarming rise in cases of HPV-
positive (HPV+) HNSCCs has been observed over the past few decades. Despite this, our understanding of the
precise mechanisms underlying HPV-driven disease progression, particularly concerning the host immune
response, remains limited.
Current immunotherapies with immune checkpoint inhibitors (ICIs) reactivate exhausted T cells. However, in
cancers like HPV+ HNSCC, downregulation of major histocompatibility complex class I (MHCI) and costimulatory
molecules hampers T-cell responses. The mechanisms behind this downregulation are largely unknown. HPV+
HNSCC patients consistently show low MHCI and costimulatory receptors on tumor cells, contributing to poor
response rates in ICI therapy. Membrane-associated RING-CH finger 8 (MARCHF8), homologous to Kaposi’s
sarcoma herpesvirus K3 and K5, downregulates MHCI through ubiquitination. Our study revealed that HPV
activates MARCHF8, promoting MHCI degradation. Knocking out MARCHF8 in HPV+ HNSCC cells increased
the expression of multiple immune receptors, including MHCI, improved mouse survival, and enhanced NK and
T cell infiltration. Notably, we also identified that the MARCHF8-mediated ubiquitination of MHCI triggers its
degradation via selective autophagy. Based on these compelling results, we propose that the MARCHF8-
autophagy axis plays a crucial role in promoting cancer progression by evading T-cell responses. This indicates
that targeting the MARCHF8-autophagy pathway could offer a promising therapeutic strategy for novel
immunotherapies to treat HPV+ HNSCC. In this project, we will 1) determine if targeting MARCHF8 activates
antitumor immunity by remodeling the tumor microenvironment of HPV+ HNSCC; 2) determine the mechanisms
by which MARCHF8 ubiquitinates and degrades MHCI proteins; and 3) develop novel immunotherapies by
targeting the MARCHF8-autophagy pathway.
Current immunotherapies using ICIs have limited success, with over 70% of patients not responding. ICI-
refractory cancers show low MHCI expression and T-cell infiltration. Targeting MARCHF8 and autophagy could
restore immune receptors and offer new treatment options for non-responders with HNSCC.

Public health relevance
PROJECT NARRATIVE An epidemic-level increase in human papillomaviruses (HPV)-positive head and neck squamous cell carcinoma (HPV+ HNSCC) requires urgent development of new tools to treat HNSCC patients. The goal of this proposal is to investigate the mechanism by which the membrane-associated RING-CH-type finger 8 (MARCHF8) ubiquitin ligase-autophagy pathway degrades immune receptors such as major histocompatibility complex class I (MHC- I) proteins and develop novel immunotherapy that restores MHC-I antigen presentation in HPV+ HNSCC.